Discovery and validation of multi-omic plasma biomarkers for Adrenomyeloneuropathy

PROJECT SUMMARY/ABSTRACT
The goal of this project is to utilize omics approaches in conjunction with machine learning tools to develop novel
prognostic and monitoring biomarkers for Adrenomyeloneuropathy (AMN), the most common adult neurologic
variant of X-linked adrenoleukodystrophy (X-ALD). X-ALD is an inherited disorder due to mutations in the ABCD1
gene. All males with a mutation and half of all females who carry a mutation in ACBD1 develop progressive
neurological symptoms affecting gait, and bowel/bladder function, and there is currently no existent therapy.
While several therapeutic strategies are rapidly emerging, the implementation of clinical trials is severely
challenged by slow and variable disease course and lack of validated monitoring and prognostic biomarkers.
Building on our prior research,
cutting edge omics techniques
the overall hypothesis of this new proposal is that by generating and integrating
evaluating metabolites and micro RNAs in patient blood plasma samples, it is
possible to identify both monitoring biomarker(s) that correlate with disease severity and prognostic biomarker(s)
that either individually or in aggregate as a biomarker signature precede clinical changes allowing the prediction
of AMN disease progression. We will test this hypothesis by in two phases in this milestone driven project. During
the initial R61 Phase, we plan to identify monitoring and prognostic biomarkers signature in longitudinal plasma
samples obtained from a cohort of AMN subjects whose blood and clinical information has already been collected
by the investigators. The identified miRNA and metabolite signature along with clinical outcome measures will
be used to create a machine learning based prediction tool. Then if successful, in the next phase, the R33 Phase,
we will validate clinical utility of monitoring and prognostic AMN biomarkers and the machine learning tool in a
new prospective multicenter cohort of AMN patients. We will accomplish our goals through a multi-disciplinary
approach which will bring together molecular biologists, neuroscientists, clinical leukodystrophy experts,
statistical experts and computer engineers with machine learning expertise. If successful, the outcome of this
research is expected to represent a necessary vertical advancement to the field and we will have (1) a clinically
assessed miRNA and metabolomic biomarker platform that is able to verify AMN disease severity as compared
to age and sex matched controls and (2) a novel machine learning based prediction tool of disease progression
in AMN.

Public health relevance
PROJECT NARRATIVE The proposed research aims to identify novel monitoring and prognostic biomarkers in a devastating neurological disorder. It is relevant to public health because if successful it will enable implementation of clinical trials and relevant information that can be used for prognosis in clinical setting. The proposed research is relevant to the part of the NINDS mission that pertains to acquiring and using fundamental new knowledge of the nervous system to decrease the burden of neurological disease.